Mito-inflammation and sepsis-induced acute lung injury

SUMMARY
Our prior work has shown that TLR4-mediated increases in mitochondrial (mt)-ROS play an essential role in the
inflammatory phase of acute lung injury (ALI) by stimulating NF-kB and nucleotide-binding domain-like receptor
protein 3 (NLRP3) inflammasome activity. However, the molecular mechanisms by which mt-ROS stimulates
inflammatory response are unresolved and are the focus of our application. The mitochondrial network
constantly forms elongated tubes through fusion and splits into small, less-connected mitochondria through
fission. Recent work has highlighted the importance of pathological mitochondrial network remodeling in human
disease. Thus, optimizing mitochondrial network dynamics is critical for mitochondrial homeostasis. We recently
discovered that TLR4 activation increases mt-ROS in lung EC by stimulating mitochondrial fission. Based on
these exciting findings, this proposal will test the hypothesis that TLR4-mediated pathological mitochondrial
network remodeling is a previously undescribed mechanism that prolongs the inflammatory phase during sepsis-
mediated ALI. Specific Aim (SA) #1 will define how TLR4-mediated mitochondrial fission requires RhoA/ROCK-
dependent cytoskeletal remodeling and evaluate the role of increased activation of the fission protein, Drp1, and
reductions in the levels of the fusion proteins MFN1 and MFN2. The involvement of nitration-mediated post-
translational modifications (PTMs) in RhoA will also be evaluated. The effect of fission-mediated mt-ROS on NF-
kB activity and NLRP3 inflammasome assembly and activation will also be evaluated. Mechanistically, we will
focus on the mt-ROS-mediated inhibition of the NF-kB regulatory protein IkBa in the sustained activation of NF-
kB. SA #1 will also delineate the involvement of JNK as a downstream target of ROCK signaling in Drp1 activation
and the decrease in MFN1/2 levels. The inhibitory effect of pathologic mitochondrial network remodeling on the
autophagy/mitophagy response in the inflammatory response will also be evaluated. Using multiple pre-clinical
mouse models, SA #2 will test new therapeutic strategies to preserve/restore the mitochondrial network balance
and determine their efficacy in attenuating the inflammatory injury associated with sepsis-induced ALI. Our
explorations are highly innovative, as they will define a concept-advancing interplay between TLR4 activation,
pathologic mitochondrial network remodeling, autophagy/mitophagy inhibition, and the inflammatory response,
opening a new avenue for therapeutic development in lung injury. Finally, these findings are highly significant,
as they will promote a more thorough understanding of sepsis pathobiology and highlight the application of novel
therapies for the critically ill.

Public health relevance
NARRATIVE/RELEVANCE: Despite recent advances in the care of the critically ill, there remains a need for an improved understanding of the pathophysiology of acute respiratory distress syndrome (ARDS). Improved therapeutic options are also needed. We propose to investigate new therapeutic approaches targeting mitochondrial network dynamics, which will result in the development of precise, individualized therapies for the critically ill.